Assessment of strategies for targeting transcriptional co-activators in colorectal cancer

Project Summary:
PGC-1 family proteins (PGC-1α, PGC-1β, and PPRC1) are transcriptional coactivators that act as central
hubs to coordinate diverse cellular inputs to promote the transcription of genes that regulate metabolism to
maintain homeostasis. Transcriptional coactivator Peroxisome Proliferator-Activated Receptor Gamma
Coactivator 1 β (PGC-1β) is over-expressed in colorectal cancers (CRC) with K-Ras mutations and promotes
the survival of tumor cells. PGC-1 family proteins lack intrinsic enzymatic activity and function by facilitating
interactions between transcription factors, epigenetic modifiers, and transcription initiation machinery. To identify
the protein-protein interactions required by PGC-1β to promote gene expression we immunoprecipitated PGC-
1β and identified binding partners by mass spectrometry. Our data reveal that Estrogen-Related Receptor α
(ERRα) and Host Cell Factor 2 (HCF2) are PGC-1β binding proteins that we propose are required for PGC-1β
to regulate the transcription of genes that promote CRC survival. Our long-term goal is to inhibit CRC growth
by blocking PGC-1β signaling and we propose that can be achieved by preventing PGC-1β from signaling
through either ERRα or HCF2. In Aim 1, we will determine the mechanism by which phosphatase PGAM5
modifies PGC-1β to increase ERRα transcription. In Aim 2, we will identify PGC-1β-HCF2 regulated genes and
determine the requirements for HCF2 signaling. In Aim 3, we will test the loss of the PGC-1β, the loss of the
PGC-1β-ERRα interaction, the loss of the PGC-1β-HCF2 interaction, and the loss of both interactions in vivo
using orthotopic submucosal injections in immunodeficient mice receiving Crispr-Cas9-modified patient-derived
tumor organoids establish from liver metastases.

Public health relevance
Colorectal cancer accounts for 8-9% of all cancer-related deaths in the U.S. in both women and men, and estimates predict it will account for 52,550 deaths in 2023. The long-term goal for this research is to provide novel therapeutic strategies to treat patients with metastatic disease by targeting PGC-1β signaling. Additionally, we hope to develop treatment strategies with tolerable side effects to lengthen and improve the quality of life after a diagnosis of metastatic colorectal cancer.